The EMBER Trial for Weight Management Engagement

Background: Almost 40% of Veterans using the Veterans Health Administration (VA) have obesity, putting
millions at risk for costly and debilitating conditions, including diabetes, cancer, and severe COVID-19. VA
weight management programs effectively reduce weight, morbidity, and mortality. For example, MOVE!, VA’s
flagship program for weight management is associated with reductions in cardiovascular disease and diabetes.
However, while 94% of eligible Veterans are offered weight management programs, less than 8% use them.
Motivational interviewing improves treatment engagement, but clinicians have limited time to apply it.
Therefore, we developed EMBER, a self-directed tool with the goal of Enhancing Motivation for Better
Engagement and Reach for weight management. It is available in paper and digital formats. EMBER is not a
weight management program, instead it engages Veterans in existing programs by informing and guiding
choices about weight management. EMBER is the product of an HSR&D Career Development Award (15-257).
Significance: If EMBER increases engagement in effective weight management programs, it has the potential
to help Veterans lose weight, thereby improving health and quality of life for thousands of patients. As a result,
we address many HSR&D priorities, e.g.,
access to care, virtual care, healthy equity, & primary care.
Innovation & Impact: EMBER is the first self-directed, motivational interviewing-based intervention designed
to increase Veteran engagement in weight management programs. As opposed to a “one-off” study in a
specific population, the proposed work takes a novel, low-touch population health approach that could be
translated to other programs (e.g., behavioral pain management). EMBER also includes vignettes relevant to
populations at high risk for obesity (e.g., women, people of color).
Further, t
he Hybrid Type 1 design will ensure
results can be scaled and sustained while also advancing implementation science. As such, the proposed work
will: 1) advance the science of engagement in behavioral health programs and 2) facilitate future research on
the implementation of EMBER and similar interventions.
Specific Aims:
1. Assess whether Veterans randomized to EMBER are more likely to have any weight management
engagement at 2-month follow-up (per administrative data supplemented with self-report) compared to
those randomized to the control arm (information sheet listing available programs). (Primary Outcome)
2. Assess whether Veterans randomized to EMBER have greater weight management program retention,
weight management behaviors (e.g., physical activity), weight loss, and quality of life gains at 6-month
follow-up compared to those randomized to the control arm. (Secondary Outcomes)
3. Assess factors likely to affect EMBER’s implementation. Preliminary implementation outcomes will be
assessed via RE-AIM4 (Reach, Effectiveness, Implementation) and the Proctor et al.5 implementation
outcomes framework (Acceptability, Appropriateness, Costs, Fidelity). (Implementation Outcomes)
Randomized two site Hybrid Type 1 Effectiveness-Implementation Trial among Veteran primary
care patients with obesity in VA (N=470). Participants will be randomized to EMBER or a control condition
consisting of a list of available weight management programs. The primary outcome is any weight
management engagement 2-months after baseline. Aims 1 and 2 will use self-report and administrative data to
assess intervention outcomes. Aim 3 will use patient data and information from research staff.
Methodology:
Implementation/Next Steps: If effective, we will use implementation strategies suggested by Aim 3 to ensure
Veterans receive EMBER. We will test these strategies in a Hybrid Type 2 trial to understand EMBER’s
effectiveness in real world contexts and best practices for dissemination and implementation of EMBER and
similar interventions.

Public health relevance
Obesity is a major cause of preventable diseases and deaths in the United States. Over 40% of Veterans using Veterans Health Administration (VA) primary care have obesity. However, less than 8% of eligible Veterans use VA’s effective weight management programs. EMBER – a novel, motivational, self-help tool – could increase Veterans’ engagement in weight management programs. Greater Veteran engagement in these programs would have a large impact on Veterans’ health, including weight loss and associated improvements in physical health, function, and quality of life. EMBER’s flexible design will facilitate the incorporation of new weight management programs as they are introduced as VA services. In addition, it may be of particular value to Veterans of color, given their high obesity rates. Finally, EMBER is patient-centered, which will facilitate Veterans’ engagement in treatments aligned with their needs and interests, while ensuring appropriate use of VA resources.